PHASE III STUDY OF SURAMIN VS PLACEBO TREATMENT IN METASTATIC PROSTATE CANCER

The objective of this Phase II study is to determine suramin's effect on pain, performance status, PSA, disease response quality of life and survival in patients with hormone-refractory prostate carcinoma and to evaluate the safety of suramin. Suramin is a polysulfonated napthylurea developed in the 1920s as a treatment for trypanosomiasis in Africa, and later found useful in the treatment of onchocerciasis and have received attention more recently as a potential antineoplastic agent because of its ability to bind to a number of peptide growth factors.